A longitudinal investigation of the cerebellum in adulthood: anatomical and network changes, motor function, and cognition

Project Summary
The project summary here is adapted from that of the parent grant R01AG064010-01. Understanding the factors
that contribute to declines in both motor and cognitive performance is crucial for helping older individuals maintain
their quality of life and independence. Further, a better understanding of the patterns of normative age-related
change is necessary in order to pinpoint diverging trajectories that may be indicative of pathology. Understanding
sex differences is also of great importance as older women are disproportionately impacted by Alzheimer’s
disease, suffer from more falls, and are more frail than older men. While research investigating the cerebral
cortex has expanded our understanding of aging, cerebellar contributions have been overlooked. The cerebellum
makes up 10% of the total brain volume, includes more than half of all the neurons in the brain, and is an
especially good target for intervention via non-invasive brain stimulation. Further, it contributes to both motor and
cognitive function, and shows sex differences in volume in older adults, that may be due in part to hormonal
changes with menopause. In the limited work investigating the aging cerebellum, its volumetric declines are
second only to those of the hippocampus. Thus, including the cerebellum in models of brain and behavioral
change represents an innovative way to improve understanding of age-related performance declines, and may
in fact do a better job than the cortex alone. Preliminary findings indicate that cerebellar declines may begin
during middle age, and that the structure is associated with motor and cognitive performance in cross-sectional
investigations of aging. Here, an expert team of cerebellar, aging, and sex difference researchers will recruit a
group of 150 healthy adults over the age of 35 (75 males, 75 females) for a 2-year longitudinal study of the
cerebellum and behavior in middle age and older adulthood. The objective of this proposal is to quantify regional
cerebellar volume, cerebello-thalamo-cortical networks, and motor and cognitive function to investigate
cerebellar and behavioral trajectories. Aim 1 will quantify changes over time in cerebellar structure and networks
to define these trajectories across adulthood and in aging. Aim 2 is designed to investigate brain-behavior
relationships and determine how cerebellar changes relate to motor and cognitive performance declines. Aim 3
will explore sex differences in cerebellar and behavioral trajectories, with a focus on the influence of menopausal
hormonal changes. The expected results stand to have a significant impact on our understanding of the aging
mind and brain and improve our models of brain and behavioral change in adulthood. Investigating cerebellar
trajectories will expand our knowledge of healthy aging and stands to provide new targets of investigation with
respect to age-related diseases, including Alzheimer’s. The proposed supplement will support Mr. Ivan Herrejon
for his first two years of doctoral education, providing him with dedicated research time outside of the typical
teaching assistant positions, and additional in-depth training. Ivan will conduct novel analyses on cerebellar-
basal ganglia connectivity, providing him training on data collection, processing and analyses, which will serve
as a foundation for his future dissertation work.

Public health relevance
Project Narrative The goal of this diversity supplement proposal is to provide Mr. Ivan Herrejon with support for the first two years of his doctoral study. Building off the investigations in the parent grant, Ivan will investigate cerebellar-basal ganglia connectivity and its relationships with both motor and cognitive behavior using the longitudinal sample collected as part of the parent grant. This will provide Ivan with dedicated research time and training, in lieu of a teaching assistantship in his second year, resulting in proficiency in resting state connectivity analysis, as well as guided training in multiple aspects of professional development.